Integrative Health Sciences Facility Core

The Integrated Health Sciences Facility Core (IHSFC) facilitates multi-directional translational research between
mechanistic, toxicological, clinical, and population-based studies to inform the scientific community, public health
policy, and education. The IHSFC furthers the mission of the Southwest Environmental Health Sciences Center
(SWEHSC) with a focus on the environmental exposures affecting human health that are unique to the diverse
populations of the Southwest. The mission of the IHSFC stems from the three SWEHSC research themes:
environmental exposures in underserved Southwest populations, environmental lung disease, and adaptive
responses to environmental stressors, which span a number of environmental exposures including organic
solvents, metals and metalloids, airborne particulate matter, and UV light exposure. To foster integrated
environmental health research, the IHSFC is organized around three operational components. The
Implementation Resource for Translational and Human Exposure Research provides strategic advice and
resource support to SWEHSC investigators in sampling Southwest human populations and their living
environment, communicating research findings with key stakeholders, and in helping investigators navigate
translational research barriers. The Data Science Resource provides statistics, bioinformatics, database
development and integration, and high-performance computing support and resources to investigators within a
model of project partnership. The Inhalation Exposure Resource provides a vital new core facility to conduct
inhalation exposure experiments in rodent and cellular models. By combining these three resource areas, the
IHSFC provides integrated services and expertise in environmental exposure measurement and modeling,
statistical modeling of the relationship between exposure and health outcomes, and mimicking real world
exposures in experimental models of disease to understand their mechanistic underpinnings. IHSFC scientists
work with investigators from all three SWEHSC research focus groups (RFGs) and Pilot Projects, serve as
mentors for Career Development beneficiaries, and work with the Cellular Imaging and Omics Facility Cores to
ensure consistent, professional statistics and bioinformatics study design, data management, and connectivity.
Finally, the IHSFC collaborates extensively with the Community Engagement Core (CEC) to leverage
established relationships with community stakeholders, identify exposures of concern to communities, assess
environmental health literacy, and identify effective strategies for communicating research results and
environmental risk to the people of Arizona and the Southwest.